Genomic- informed development of a cheap, portable assay to rapidly profile drug-resistant bacterial infections

Project Summary
Antimicrobial-resistant (AMR) infections are a global health crisis, causing nearly 5 million deaths
annually, with the highest burden in low- and middle-income countries (LMICs). Carbapenem-resistant
Enterobacterales (CRE) are among the most dangerous AMR pathogens because they are resistant to nearly
all antibiotics. CRE acquire this resistance mainly through two mechanisms: i) carbapenemase production and
ii) changes in their cell structure (porin deficiency) that prevent antibiotics from entering the bacteria. Although
porin deficiency causes about 15% of CRE, the exact impact of different porin mutations—especially in regions
like Latin America—remains poorly understood. Additionally, the lack of rapid, affordable diagnostic tools in these
areas delays effective treatment, leading to higher mortality, especially in cases of bloodstream infections. To
address these challenges, I developed BADLOCK, a CRISPR-based diagnostic test that can rapidly identify
bacterial species and AMR genes from blood cultures. BADLOCK is affordable, portable, and designed for
resource-limited settings, aligning with World Health Organization recommendations. Preliminary data show it
can accurately detect common bacteria and resistance genes, making it a promising tool for use in LMICs.
This proposal focuses on characterizing porin mutations and expanding BADLOCK’s capabilities. I will
sequence the genomes of a completed cohort of over 500 Enterobacterales isolates from Peru to identify porin
mutations (among other AMR determinants), assess their contribution to resistance through genomic
comparisons with other CRE cohorts, and conduct lab experiments to confirm the role of these mutations.
CRISPR guides will be developed using novel computational strategies to target diverse species, common AMR
genes, and validated porin mutations, thereby improving BADLOCK’s utility. Finally, it will be piloted in Peruvian
hospitals to evaluate its performance in real-world settings. This project will improve diagnostic capacity in
resource-limited settings and create the first catalog of isogenic strains with porin mutations. Additionally, it will
provide critical insights into resistance mechanisms and support more effective management of bacterial
infections in LMICs.
As an infectious disease physician with an extensive background in bacterial genomics, I am well-poised
to carry out these research goals. However, this proposal includes an ambitious training and career development
plan that will further enhance the molecular biology and global health research skills necessary to launch my
career as an independent, R01-funded investigator. The robust scientific and educational resources of Harvard
Medical School and the Broad Institute provide an excellent training environment, and I have built a mentorship
team consisting of world leaders in bacterial genomics, infectious disease diagnostics, and global health – all of
whom are committed to supporting me in my success as an independent researcher.

Public health relevance
Project Narrative Antibiotic-resistant bacterial infections are one of the leading causes of mortality worldwide with an especially high burden in low-resource environments, where the medical infrastructure necessary to detect them is limited; novel diagnostics are urgently required to address this gap. The investigators have collected a large cohort of highly resistant clinical isolates from Peru which will undergo whole-genome sequencing with comparison to other sequenced cohorts to assess shared porin mutations, and have simultaneously developed a prototype assay capable of rapidly diagnosing bacterial infections of the bloodstream. In this proposal, they will use insights from the analysis of the bacterial genomes to enhance the clinical utility of their assay, deepen our understanding of the genetic drivers of resistance, and validate a novel platform to detect resistant infections in low-resource settings.